Core A: Biospecimen Repository

PROJECT SUMMARY/ABSTRACT The Biospecimen Repository Core is designed to provide support to the basic translational research efforts of the SPORE. The Core will continue to play a central role in collecting, annotating, storing, distributing, and tracking prostate cancer tissue and blood biospecimens from patients enrolled in research protocols. Detailed biospecimen annotation, including documentation of pre-analytic processing variables, pathology findings, and patient clinical history information will be recorded in robust relational databases. We will conduct rigorous data quality assurance and quality control measures, and standardized longitudinal follow-up of all consented patients with materials in the prostate biospecimen repository. The Core will provide SPORE investigators with expert histopathological evaluation of tumor samples both from patients enrolled on research protocols and from xenograft models. The Core will also provide assistance in performing and interpreting immunohistochemical and in situ hybridization assays, in selecting tissue for microdissection and construction of arrays, and in collaborating with project leaders and the Biostatistics and Bioinformatics Cores. Specific Aim 1. To maintain and expand a model prostate cancer resource to collect, annotate, store, and distribute biospecimens for translational prostate cancer research Specific Aim 2. To perform systematic pathologic evaluation of all human and animal tissue samples and preparation of appropriate tissues for use by SPORE investigators Specific Aim 3. To collect, process, annotate, store, and distribute blood specimens under Clinical Laboratory Improvement Amendments (CLIA)-regulatory conditions for use by SPORE investigators

Public health relevance
PROJECT NARRATIVE Through the work of the MSKCC SPORE in Prostate Cancer, supported by the Biospecimen Repository Core, we hope to increase our understanding of the clinical, biologic, and genetic basis of prostate cancer to improve patient outcome, to facilitate a range of scientific activities that could lead to new genomic- and proteomic- based interventions for cancer, including target identification and validation, and to develop new biomarkers, diagnostics, and pharmacogenomic analyses